Postdoctoral Training, Neurobiology of Aging and Alzheimer's Disease

Project Summary/Abstract
The postdoctoral training grant entitled “The Neurobiology of Aging and Alzheimer's Disease” is submitted
through the University of Arizona on behalf of the Arizona Alzheimer's Consortium. The training faculty chosen
from the Consortium consist of highly interactive investigators whose scientific interests include aging,
Alzheimer's disease (AD) and AD-related dementias (ADRD) and spans fly, rodent, and nonhuman primate
models of aging, as well as human studies in normative and pathological conditions of aging. Six institutions
within the Consortium contribute Primary Mentors (Preceptors) and Affiliate Faculty to this Training Program,
including: The University of Arizona, Arizona State University, Barrow Neurological Institute, Banner Sun
Health Research Institute, The Translational Genomics Research Institute, and Banner Alzheimer's Institute.
Faculty have complementary strengths in brain imaging, computer science, genomics, molecular biology, basic
systems, behavioral and cognitive neuroscience, experimental therapeutics, computational and statistical
analyses of complex datasets and clinical neuropathological approaches. The research is aimed at promoting
the scientific understanding of the aging brain, early detection of AD and ADRD and developing effective
treatment and prevention therapies. Fellows benefit from a 4 person Professional Development Committee
(PDC) whose purpose is to provide guidance on the creation of a collaborative experimental training plan that
fosters opportunities to work, learn and produce across institutions. The primary research Mentor, in whose
laboratory the Fellow is based, is chosen from the Preceptor list, as is the secondary research Mentor, but they
can be from any institution amongst the consortium. The secondary Mentor plays an active role in the
research undertaken by the Fellow, which goes beyond making facilities available. A tertiary Mentor is
selected on the basis of experimental or pedagogical expertise, and a fourth member of the PDC is chosen
from amongst the 6-person leadership team to provide an additional level of oversight. Exposure to the unique
Arizona tradition of cooperation and collaboration that knows no institutional boundaries has significantly
enriched the skill sets and professional development of our Fellows during the training period. In addition to
multi-laboratory research exposure, another unique programmatic aspect takes the form of three workshops
per year, varying from 1-3 days, in which all Fellows participate. These include statewide events that Training
Faculty attend (Annual Arizona Alzheimer's Consortium Retreat), or that faculty, graduate students and
postdocs attend (Alzheimer's Consortium Annual Scientific Conference), as well as broader participation in
national and international professional events (e.g., Society for Neuroscience meeting). Our goal to give the
Fellow the freedom to draw broadly from facilities and expertise across the Consortium has exposed our
Trainees to the power of collaborative, interdisciplinary interactions that can facilitate development of strong
experimental designs to test important questions, providing the foundation for productive future work.

Public health relevance
Project Narrative This is an application for renewal of a training grant for postdoctoral and clinical fellows in the area of Neurobiology of Aging and Alzheimer's Disease. The 29 faculty acting as Preceptors in the training program are chosen from the Arizona Alzheimer's Consortium and have complementary research interests that span basic and clinical science, including brain imaging, computer science, genomics, systems, cognitive and molecular neuroscience, experimental therapeutics and neuropathological approaches to the study of the aging brain and early detection and treatment of Alzheimer's disease (AD) and AD-related dementias (ADRD). The program offers a unique collaborative and interdisciplinary research experience designed individually for each Fellow to provide the next generation of independent investigators the tools needed to enable them to contribute in significant ways to an understanding of cognitive decline in aging, AD and ADRD, so that preventions and treatments can be effectively developed.